Perinatal care as a venue to reduce opioid overdoses and hepatitis C virus incidence (PreVenT OD HCV)

PROJECT SUMMARY/ABSTRACT
Amidst the current opioid overdose crisis, 1.4 million women of reproductive age report non-medical opioid
use, and opioid use disorder (OUD) prevalence among pregnant women rose five-fold from 1998-2017.
Although pregnancy may be a motivating time to start medications to treat OUD, retention post-partum
declines significantly and is associated with unacceptably high opioid overdose and mortality rates. Injection
drug use is also the primary risk factor for hepatitis C virus (HCV) infection in the United States (U.S.). Women
now comprise nearly half of new HCV infections, and HCV seroprevalence has also risen five-fold in pregnant
women since 2000. Although the U.S. is committed to eliminating HCV, about 50% of people are unaware of
their infection and fewer than 40% of those diagnosed have been treated. Research is needed to identify
venues to increase efforts to improve OUD treatment and retention and to identify and treat current
HCV infection. Perinatal care provides longitudinal access to women over a nearly one-year period,
and as pregnancy may be a motivating time for women to seek care for both OUD and HCV, perinatal
care may be a critical venue to reach women who inject drugs, a key population that NIDA identifies as
central to the ongoing opioid crisis. Yet, little data exist to measure the role of the perinatal care venue to
reach national OUD and HCV treatment goals. This study aims to create a perinatal-specific decision model
and measure health service utilization and costs of a perinatal OUD and HCV intervention to identify how to
leverage the perinatal care venue to decrease postpartum opioid overdoses and population-level HCV
transmission. This study has two main aims: (1) to build a microsimulation model to analyze the clinical and
health economic effects of leveraging the perinatal care venue to reduce opioid overdoses and population-level
and infant HCV transmission; (2) to measure health services utilization and costs of incorporating MOUD and
HCV treatment into perinatal care. The results of this study could help determine most efficient resource
allocation to achieve national overdose and HCV elimination goals. The PI, Dr. Epstein, is an early career
investigator, trained in pediatric and adult infectious diseases, with a focus on addiction medicine and HCV in
pregnant women and youth. This career development award will allow her to gain expertise in 1) transmission
modeling and model calibration and 2) health economic evaluation and micro-costing to be able to conduct
comparative cost-effectiveness research to inform interventions for women with substance use and HCV. She
has compiled an experienced team of mentors and advisors to help her achieve her training and career goals,
to become an independent clinician-investigator expert in utilizing decision science to project most effective
use of resources to improve care for families at the center of the opioid overdose, HCV and HIV epidemics.

Public health relevance
PROJECT NARRATIVE As opioid use disorder (OUD) and hepatitis C virus (HCV) infection prevalence continue to rise in the United States, particularly among young women, new strategies are needed to identify high-impact venues to address both epidemics together. Pregnancy is a motivating time for women to engage in care for both their own health and that of their families. This project will utilize programmatic and public health data and simulation modeling to project the clinical and cost-effectiveness of employing interventions in the perinatal care venue to reduce opioid-related mortality and HCV transmission.